Team-Based Design of Biomedical Devices

DESCRIPTION (provided by applicant): This proposal describes a program in team-based design of biomedical engineering devices, dedicated to training undergraduate students. Students will participate in specialized courses in biomedical instrumentation, clinical rotation, and translational biomedical engineering. Five students will be selected to engage in a clinical immersion in the summer between the junior and senior years. The students' knowledge and experience will feed into a senior capstone design course, where they will perform open-ended design and fabricate a prototype medical device. A major goal of this research education program is to meet the demands of a growing biomedical engineering field and needs for an interdisciplinary workforce. The University of Arizona is well positioned to provide this research education program due to a strong history of biomedical engineering research, close ties (and physical proximity) between the Colleges of Engineering and Medicine, abundant resources for design and prototyping, and a strong existing interdisciplinary senior capstone design course. A graduate interdisciplinary program in biomedical engineering has served for the last 12 years as a nexus for faculty across campus who engage in biomedical engineering- related research and education, including a group of physician faculty who are committed to engineering student mentoring. The formation in the last year of a department of Biomedical Engineering and authorization of an undergraduate degree program has put into place the final pieces needed for the success of this program. Because of the relative newness of our undergraduate program, the resources from the proposed project would have a major positive impact on our students. We propose to augment BME courses with new educational material and guest speakers, provide a unique clinical immersion experience, and provide additional mentors and supply funds to students the interdisciplinary design course. This program will enable us to educate the biomedical engineers of the future, who have strong engineering design skills, knowledge of the clinical environment, and training in translational biomedical engineering that will enable them to take their devices from the laboratory to the clinic and the marketplace, positively affecting human health.

Public health relevance
PUBLIC HEALTH RELEVANCE: Based on Labor Department job growth projections, Biomedical engineering will lead employment growth in the next 10 years. Biomedical engineers with strong team-based design skills are needed to further medical innovation and create new medical devices. We propose an undergraduate research education plan that will educate students in the clinical environment, design process, regulatory requirements, and responsible conduct of research, culminating in a senior capstone design project. Based on Labor Department job growth projections, Biomedical engineering will lead employment growth in the next 10 years. Biomedical engineers with strong team-based design skills are needed to further medical innovation and create new medical devices. We propose an undergraduate research education plan that will educate students in the clinical environment, design process, regulatory requirements, and responsible conduct of research, culminating in a senior capstone design project. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The overall goal of the proposed research education program is to meet the growing demands for biomedical engineers trained in interdisciplinary team-based design. Given the University of Arizona's historic strengths in implants and medical instrumentation, we will focus our program on biomedical devices. The College of Engineering already has in place an outstanding interdisciplinary senior capstone design course (ENGR 498). This course will form the cornerstone of the biomedical engineering (BME) design curriculum, although several augmentations are necessary to meet the needs and goals of a modern biomedical engineering design education. For our nascent undergraduate degree program, we have proposed coursework and resources to enhance this team-based design experience for BME students. We have a rich environment in biomedical engineering research, strong interdisciplinary support, and an excellent senior capstone design course to build upon. A diagram of our proposed program is shown in Figure 1. All biomedical engineering students, and all participants in this program, are required to take a series of three BME courses in their junior and senior years: Bioinstrumentation Lab, Clinical Rotation, and Translational Biomedical Engineering. Five students will be selected to perform a Clinical Immersion in the summer between their junior and senior years. These experiences will feed into the Engineering Capstone Design course, which also will be augmented by resources available from this grant. BME 330L Bioinstrumentation Course and Lab Clinical Immersion BME 497G Clinical Rotation BME 480 Translational Biomedical Eng. ENGR 498 Senior Capstone Design Mentoring Supply and Shop Assistance Figure 1 Elements of the proposed program. Three courses are required of all biomedical engineering majors and participants in this program. A paid clinical immersion will be performed by 5 selected students. These experiences feed into the senior interdisciplinary capstone design course. Funds will be available for supply and prototype shop assistance, and all groups will benefit from engineering, clinical, and industrial mentoring. Overall, the following elements are new to the proposed program: - Understanding of the clinical environment - Design planning with clinical mentors - Intellectual property and commercialization - Regulatory requirements - Significant training in the ethical conduct of research These elements are covered in the sequence of courses and through additional mentoring. New material and lectures by experts in medical device design will be incorporated into the coursework. A clinical engineering mentor will consult with senior capstone groups on the hospital environment and safety. Additionally, physician mentors will be assigned to each project team. For select students a clinical immersion between the junior and senior year will allow for a unique experience, where they will perform clinical research and participate in a curriculum on medical ignorance. This curriculum will instruct them to realize the boundaries of their ignorance, ask questions, and understand and embrace uncertainty in medicine. The resources from this grant, together with support from the University of Arizona, will enable us to educate the biomedical engineers of the future, who have strong engineering design skills, knowledge of the clinical environment, and training in translational biomedical engineering that will enable them to take their devices from the laboratory to the clinic and the marketplace, positively impacting human health.